A Prospective Approach for the Early Detection of Infectious and Noninfectious Lung Diseases Following Allogeneic Hematopoietic Stem Cell Transplantation

The primary goal of this proposal is to integrate pulmonary imaging with lung and blood biomarkers to improve the early detection of infections and inflammatory injury after allogeneic HSCT. These data may provide early identification of patients at risk for non-infectious lung diseases and accelerate the development of targeted therapies.

Project aims:
Aim 1. To use preemptive assessments with sequential chest imaging and bronchoalveolar lavage (BAL) measures to provide earlier identification of lung injury due to infection or alloreactive lung syndromes associated with HSCT

Aim 2. To use high density proteomic, transcriptomic and metagenomic analysis of specimens from the lung and blood to define mechanisms of altered lung function associated with HSCT.

Aim 3. To serve as a pilot study to assess the feasibility of this approach for a future multicenter trial.

The protocol 001742 has undergone internal and external scientific review, radiation safety review, and PRIA evaluation, and is being presented to the IRB in September 2023. Enrollment is expected to start after that time.